Children's Oncology Group NCI Community Oncology Research Program (NCORP) Research Base Grant

NCI Diversity Supplement Abstract
This application is a diversity supplement to the Children’s Oncology Group (COG) National Cancer Institute
(NCI) Community Oncology Research Program (NCORP) Research Base Grant (UG1CA189955). Financial
distress in parents/guardians (“parents”) of children and adolescents undergoing treatment for ALL is being
evaluated by the NCI approved protocol ACCL20N1CD that is funded under the COG NCORP Research Base
Grant. This COG parent protocol leverages the NCORP network to collaborate with Community and
Minority/Underserved pediatric cancer institutions across the U.S. to recruit diverse participants and improve
the generalizability of the research findings.
Financial distress is the psychological distress related to money resulting from harmful financial burden
of cancer care. ALL is the most common type of childhood cancer with treatment requiring over two years of
frequent outpatient and inpatient visits. This prolonged and complicated treatment regimen contributes to
financial toxicity and financial distress. Financial distress may then precipitate financial coping behaviors that
negatively impact cancer treatment adherence. Certain family characteristics, such as Latinx ethnicity or
preferred language other than English, are associated with a greater risk of financial distress. The knowledge
of Latinx ethnicity or preferred language other than English as risk factors for financial distress and the overall
clinical impact of financial distress in childhood cancer is limited.
Joanna Robles, MD, is a bilingual Latina early career physician scientist at Wake Forest University
School of Medicine, with a background in pediatric cancer disparities and a long-term goal of improving
equitable cancer care delivery and quality of life for underserved populations. As a diversity supplement to the
parent protocol, she proposes to: 1) To qualitatively explore the experiences of language and cultural barriers
on Latinx and/or Spanish-speaking parents regarding financial burden including financial distress screening
and financial navigation services provided during their child’s treatment for ALL, 2) To describe characteristics
of financial distress screening and financial navigation at NCORP sites that serve pediatric cancer patients.
Our hypothesis is that pediatric cancer sites serving higher percentages of Latinx and Spanish-speaking
populations will be less likely to provide financial distress screening and navigation services and Latinx and/or
Spanish-speaking parents will report financial distress is increased by cultural and language barriers. The
findings from this supplement will highlight potential opportunities for future interventions targeting financial
distress in Latinx families of children undergoing pediatric cancer treatment.

Public health relevance
NCI Diversity Supplement Project Narrative The proposed project has the potential to increase our understanding about how Latinx ethnicity or preferred language other than English may affect the experience of financial distress for families of children with newly diagnosed acute lymphoblastic leukemia. This project will also help us understand financial distress screening and navigation services at pediatric cancer centers across the United States. The findings of the study will help us develop tools to improve financial distress for Latinx and Spanish-speaking families of children with cancer.